Mechanism of Translation Initiation on Leaderless mRNAs

SUMMARY
Leaderless mRNAs lack a 5’ UTR and SD sequence. Such mRNAs are common in Bacteria and Archaea, with
Mycobacteria being the most striking example, as about one-third of mycobacterial mRNAs are naturally
leaderless. Leaderless translation is part of a stress response and adaptation mechanism in bacteria. In
contrast to the well-understood Shine Dalgarno-containing mRNAs, very little is known about the initiation
mechanism of leaderless mRNAs. Biochemical, experimental, and systematic analysis of leaderless mRNA
expression suggested that leaderless mRNAs are translated and regulated via alternative mechanisms.
However, how this initiation is occurring and regulated remains unknown. Thus, to understand bacterial
physiology and antibiotic resistance, we need to reveal the molecular mechanism of leaderless translation.
This proposal aims to address this need. We will use single-molecule methods that are particularly well suited
for the dissection of dynamic processes, such as translation. We developed a single-molecule fluorescence
system that allows us to observe the entire initiation process. We can directly follow mRNA, ribosomal
subunits, and translation factors, thus defining how initiation is occurring and regulated. In aim 1, we will
determine how leaderless mRNAs are recruited to the ribosomes and how the start codon is recognized. We
will directly test for the existence of the proposed alternative initiation mechanisms. Namely, we will define if
mRNAs are directly recruited to the 70S ribosomes. We will then determine if start codon recognition is
concurrent with mRNA recruitment, as was previously proposed. We will also determine the role of initiation
factors in regulation of leaderless translation. In Aim 2, we will focus on the roles of mRNA sequence and
structure. Translation efficiency of leaderless mRNAs is regulated by the start codon sequence, presence of
nucleotides upstream of the start codon, and mRNA secondary structure. We will use our single-molecule
toolkit to determine how these elements regulate translation. In particular, we are interested in how they affect
alternative initiation pathways.

Public health relevance
NARRATIVE Bacteria use non-canonical mechanisms of protein synthesis, such as leaderless mRNAs, to rapidly remodel their proteome. However, very little is known about how this process occurs and how it is regulated. Here, we are using single-molecule microscopy to reveal these mechanisms and bridge this gap.